Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
For this program project, we will establish a bioinformatics core to process and analyze the large amount of data
that will be generated by its four projects. We propose a comparative study of genome maintenance and its
molecular and cellular end points in relation to human aging. While our work in the past has led to the conclusion
that defects in genome maintenance systems have detrimental molecular, cellular and physiological effects that
mimic normal aging, there is uncertainty about the most relevant pathways involved and their relative functional
importance, especially for human aging. Lack of this information is an important problem, because, without this
knowledge, acquiring the ability to modulate aging on the whole organism level is highly unlikely. Our long-term
goal is to understand the mechanisms that determine longevity. The overall objective of the bioinformatics core
is to provide computational support and service to the project investigators, i.e., work with each project to handle
data generated therein and to integrate data from all projects to achieve the aims of the program project grant
as a whole. The central hypothesis of this Program is that defects in genome maintenance result in deleterious
molecular and cellular outcomes caused by unrepaired DNA damage, including genome instability, transcription
stress, and cell fate changes, which in turn drive the pathogenesis of both cancer and aging. This hypothesis
has been formulated on the basis of a large body of data produced in this PPG. The rationale for a dedicated
bioinformatics core is that a consolidated facility is needed to manage the large amount of data on the whole
genome level generated by each of four highly integrated projects of this program project. This bioinformatics
core will be established to achieve three specific aims: 1) To develop a web portal to warehouse and share data
generated by the four projects; 2) To facilitate projects by processing and analyzing the data that they generate;
3) To integrate project data at the systems level and identify a genetic network of genome maintenance in aging
and longevity. The function of the bioinformatics core is significant, because it will be set up to meet the challenge
posed by the high volume of data that need to be generated, examined at multiple levels by a variety of
approaches, integrated to develop the models of lifespan control, and shared among project investigators and
the scientific community as a whole.

Public health relevance
PROJECT NARRATIVE The proposed bioinformatics core is relevant to public health because a web data portal and novel computational methods will be developed to tackle the genetic bases and molecular mechanisms of cellular aging related to DNA damage repair and its molecular and cellular end points. The web data portal will also be used to disseminate the data to the larger research community. The proposed research is directly relevant to the NIA mission in that it pertains to developing fundamental knowledge that will help reduce the burdens of human disabilities associated with advanced age.